Mutational profiling in human cells as an in vitro alternative to in vivo mutagenicity assessments

PROJECT SUMMARY
Mutations are heritable changes in the cellular genome and are key events in the induction of cancer, birth
defects, and neurological diseases. The lack of a mutagenicity bioassay in human cells is a major data gap in
the genetic toxicology test battery used by regulatory agencies for hazard identification and quantitative risk
assessments. ScitoVation is developing a New Approach Methodologies (NAMs) combining human cells and
Error Corrected Next Generation Sequencing as an in vitro alternative to current regulatory mammalian cell
mutagenicity assessment using rodent cell lines, and as an in vitro alternative to in vivo mutation assays.

Public health relevance
PROJECT NARRATIVE Mutations are heritable changes in the cellular genome and are key events in the induction of cancer, birth defects, and neurological diseases. Screening chemicals for their potential to cause mutation in a human- relevant assay offers an effective strategy for improving public health. The lack of a mutagenicity bioassay in human cells is a major data gap in the genetic toxicology test battery used by regulatory agencies for hazard identification and quantitative risk assessments. Current human cell mutagenicity bioassays are labor intensive and rely on 50-year-old clonal selection techniques. Error Corrected Next Generation Sequencing (EC-NGS) is a direct method for analytical assessment of mutagenicity with precise quantification of these very rare events in DNA. The focus of this Direct-to-Phase II SBIR application is to develop a New Approach Methodologies (NAMs) combining human cells and EC-NGS as an in vitro alternative to current regulatory mammalian cell mutagenicity assessment using rodent cell lines, and as an in vitro alternative to in vivo mutation assays. The development of human cell mutagenicity assays will be part of ScitoVation’s nonanimal Next-Generation genotoxicity assessment using NAMs and dosimetry to improve human safety assessments. We will accomplish this by defining experimental parameters to quantify the induction of mutations by EC-NGS in two distinct human cell lines: TK6 lymphoblastoid cells and metabolically competent human HepaRG™ cells. Although EC-NGS is highly innovative and a “game changer,” without integration into well-defined human cell-based systems and careful validation studies, its application in regulatory Genetic Toxicology is limited. Human TK6 cells are a well- established and validated cell line with worldwide acceptance for mutagenicity assessments. However, TK6 cells lack drug-metabolizing enzymes. Metabolically competent human liver HepaRG™ cells express Phase I and Phase II drug metabolizing enzymes and have been used to assess genotoxicity. However, the requirement for two rounds of cell cycling to fix DNA damage into mutations, the prolonged cell cycling time of 10-14 days, and lack of clonal selection techniques to quantify mutations in HepaRG™ cells have precluded the development of mutagenicity testing in HepaRG™ cells. In this SBIR, we aim to replace 50 yr. old clonal selection techniques to assess mutation in mammalian cells by using EC-NGS to quantify mutations in human TK6 and HepaRG™ cells. Specific Aim 1 – Define experimental parameters to assess mutagenicity by EC-NGS in human TK6 cells and validate TK6 EC-NGS as a replacement for current mammalian cell in vitro mutagenicity testing bioassays. Specific Aim 2 – Define experimental parameters to assess mutagenicity by EC-NGS in HepaRG cells and validate HepaRG™ EC-NGS as a replacement for in vivo mutagenicity assessment in rodents. Completion of this Phase II SBIR will produce two human cell-based mutation assays that can be used as a follow-up to bacterial mutation assays and as a NAM to reduce reliance on current in vivo gene mutation assays in rodents. These assays will be a cornerstone of ScitoVation’s NAMs-based vision on Next Generation genotoxicity assessment using human-relevant cell-based models and dosimetry for human safety and risk assessments.